Project 1: Drivers of interannual and intrabloom toxicity dynamics in Gulf of Maine HABs

Alexandrium catenella and Pseudo-nitzschia spp. threaten human health through their production of potent
neurotoxins that respectively cause Paralytic Shellfish Poisoning and Amnesic Shellfish Poisoning. Both are
widespread across coastal waters of the U.S. and globally. Environmental factors alter marine ecosystems in
many unanticipated ways, and a major concern is that the occurrence of these harmful algal blooms (HABs)
and their concomitant human health impacts will grow. This project addresses key uncertainties regarding the
impact of environmental variability on the timing and severity of HABs through detailed biological and
ecological study of Alexandrium and Pseudo-nitzschia blooms within the Gulf of Maine (GOM). The GOM is an
ideal system because of the long history of regional HAB issues and associated groundbreaking research by
WHCOHH. Comprehensive studies of bloom physiology, toxicity, and oceanographic drivers have led to
construction of coupled physical-biological models that have improved our understanding of key HAB dynamics
and set the stage for continued interdisciplinary investigation of mechanisms at the cellular-to-GOM scale that
are relevant to human exposure and health. In particular, the physiological responses of these HABs —
growth, toxicity, and life cycle transitions — to shifting environmental conditions remain uncertain. We
hypothesize that long-term trends in HAB risks in the GOM are inherently linked to physiological processes and
toxin dynamics that are driven by ecological stimuli. This project’s aims are designed to illuminate the role of
life cycle dynamics and cellular physiology in determining the occurrence of Alexandrium and Pseudo-nitzschia
blooms. We apply a wide variety of innovative approaches for study of natural populations in situ, leveraging a
unique region-scale HAB observing system (HABON-NE). Aims 1 and 2 focus on A. catenella and seek to
characterize cyst dormancy cycles, cyst formation, and subsequent bloom termination. These aims build upon
prior successful approaches and models from study of inshore systems, asking the question if open water
populations of the GOM are governed by similar dynamics. Aim 3 investigates the physiology underlying the
emerging bloom dynamics of Pseudo-nitzschia in the GOM with in situ physiological observation coupled with
targeted metatranscriptomics. Through the direct assessment of life cycle processes and physiology of HABs
in the GOM, the results from this work will be directly applicable to the successful integration of physiology into
models (Project 2) and inform estimates of potential risk for human exposure to HAB toxins (Project 3).